Regulation of GSK3B degradation and its role in acute lung injury

PROJECT SUMMARY Acute respiratory distress syndrome (ARDS) is a major cause of mortality in critically ill patients in the US. Pharmacologic therapies for ARDS have been largely unsuccessful in decreasing mortality. Patients suffer from severe hypoxemia caused by acute inflammation, lung epithelial and endothelial cell damage, and capillary leakage of protein-­rich fluid into alveoli. Studies from our laboratory have shown that dysregulation of protein degradation alters lung inflammation in experimental models of ARDS. The long-­term goal of our research is to identify therapeutic targets to decrease inflammation in ARDS and reduce mortality. The ubiquitin-­proteasome pathway (UPP) is responsible for most protein degradation in cells. This irreversible process is critical to maintaining cell homeostasis. Failure to regulate protein stability can lead to tissue damage from unchecked inflammation. Glycogen synthase kinase-­3β (GSK3β) is a highly conserved serine-­threonine kinase and key regulator of cell differentiation, metabolism, and inflammation. Phosphorylation of key proteins by GSK3β has many biological functions, one of which is targeting substrates for degradation by the UPP. Studies have shown that GSK3β mediates deleterious lung inflammation in murine models of sepsis and ARDS. Despite its critical role in cell biology, little is known about how GSK3β stability itself is regulated, particularly in the context of lung inflammation. The goals of our project are 1) to define mechanisms of GSK3β degradation in lung epithelial cells;? 2) to determine how inflammation affects GSK3β kinase activity and protein stability in pathways relevant in ARDS;? and 3) to identify novel E3 ligases that regulate GSK3β stability in models of ARDS. Using a cycloheximide chase assay to study the lifespan of GSK3β, we will overexpress mutant GSK3β in murine lung epithelial (MLE) cells to determine which lysine residues and structural motifs are required for degradation. We will also use inflammatory stimuli including LPS and TNFa? and overexpress mutant forms of GSK3β to determine how GSK3β kinase activity alters its stability in MLE cells. Finally, we will screen a library of F-­box proteins to identify a novel E3 ubiquitin ligase complex that degrades GSK3β and study the effects on inflammatory responses in lung epithelial cells. This work will elucidate potential targets for novel therapies to reduce mortality in ARDS. As a pulmonary and critical care medicine fellow in the Acute Lung Injury Center of Excellence at the University of Pittsburgh, she is mentored by Drs. Rama Mallampalli and Yutong Zhao to become proficient in laboratory models of acute lung injury. As a postdoctoral research fellow her training will focus on advanced laboratory techniques in biochemistry, molecular and cellular biology, and molecular immunology. Early career development opportunities include didactic training, conference attendance and presentations, and publications and that will be guided through mentoring by her co-­sponsors. The support of the National Research Service Award for this proposal will serve as the foundation for accomplishing her goal of becoming an independent and successful physician-­scientist.

Public health relevance
PROJECT NARRATIVE Acute respiratory distress syndrome (ARDS) is a major cause of mortality in the US with patient deaths resulting from low oxygen levels driven by lung inflammation. Evidence suggests that destruction of critical proteins regulates lung inflammation, and glycogen synthase kinase- 3β (GSK3β) is an important mediator of this process. These studies focus on understanding how destruction of GSK3β itself influences lung inflammation with the goal of identifying new therapeutic targets for ARDS.